Transcription Factor Discovery in the Opportunistic Pathogen Pseudomonas aeruginosa

Project Summary
Pseudomonas aeruginosa is a gram-negative, aerobic/facultatively anaerobic, rod-shaped
bacterium that is commonly found in freshwater environments. However, P. aeruginosa can
become an opportunistic pathogen, causing increased morbidity and mortality in
immunocompromised hosts, burn victims, and cystic fibrosis patients. For example, more than
two million people are infected by P. aeruginosa annually, resulting in almost 90,000 deaths.
Notably, the environmental versatility of P. aeruginosa, its multiple mechanisms for providing
antibiotic resistance, and its wide range of dynamic defenses (e.g., biofilm formation), render P.
aeruginosa a most challenging organism to effectively treat, even in today’s hospital settings.
The genes responsible for P. aeruginosa virulence are regulated by a host of sequence-specific
transcription factors. Unfortunately, our knowledge regarding their transcriptional regulatory
networks and how they can be modulated is woefully incomplete. Our laboratory has developed
an iterative selection method, Restriction Endonuclease Protection Selection and Amplification
(REPSA), that has proven highly successful in identifying consensus DNA binding sequences
and target gene promoters for a variety of transcription factors in bacteria such as Escherichia
coli and Thermus thermophilus. We now propose to use REPSA to identify the binding sites and
genes regulated by the MerR-family of transcription factors in P. aeruginosa, which are thought
to be involved in mediating responses to environmental stimuli, e.g., oxidative stress, heavy
metals, and antibiotics, involved in pathogenesis. Ultimately, such studies will illuminate global
regulatory networks in this important pathogen, thereby facilitating the development of novel
anti-P. aeruginosa therapeutics.
Notably, per the goals of the SuRE award mechanism, this project will support the research
activities of the PI, a former NIH grant recipient, and will enhance the training opportunities of
undergraduate and master’s graduate students at a primarily undergraduate/majority-minority
institution, a major focus for the PI. An award will allow the PI to continue a record of training
students who have gone on to further biomedical education in graduate or professional schools
and/or pursuing careers in STEM industries. It will also allow the PI to apply the skills honed
through continuous NSF-funded basic research to questions of direct relevance for human
health.

Public health relevance
Project Narrative Pseudomonas aeruginosa is the cause of most hospital-acquired infections, infecting more than two million people annually and resulting in almost 90,000 deaths. Notably, the environmental versatility of P. aeruginosa, its multiple mechanisms for antibiotic resistance, and its wide range of dynamic defenses (e.g., biofilm formation), render it a most challenging organism to effectively treat. Understanding the proteins that regulate these processes (e.g., transcription factors) will illuminate new pathways and targets for the development of anti-P. aeruginosa therapeutics.